ORAL VS INTRAVENOUS CORTICOSTEROIDS IN TOXICITY OF OPTIC NEURITIS

This study will assess (1) if treatment of acute optic neuritis with oral ir intravenous corticosteroids reduces residual visual dysfunction present following resolution, (2) if corticosteroids speed recovery of visual function, and (3) if complications of corticosteroid treatment are insignificant compared with the magnitude of treatment effect.